GENETIC ANALYSIS OF LEGIONELLA PHAGOSOME TRAFFICKING

DESCRIPTION (Adapted from the applicant's abstract): Infectious pathogens have devised strategies to evade host defenses. Intracellular respiratory pathogens such as Mycobacterium tuberculosis, Chlamydia pneumoniae, and Legionella pneumophila are all able to block phagosome-lysosome fusion, an important virulence determinant that allows these bacteria to replicate inside of mammalian cells. L. pneumophila is able to grow within alveolar macrophages in the lung. The dotA gene of L. pneumophila is required for intracellular growth and inhibition of phagosome-lysosome fusion. DotA is one of the only bacterial virulence factors identified that has a demonstrated role in blocking phagosome maturation in macrophages. DotA membrane topology suggests that this protein works in association with other L. pneumophila proteins to regulate phagosome trafficking in macrophages. The goal of the proposed research is to understand at a molecular level how L. pneumophila are able to regulate phagosome trafficking. Toward this end a mutational analysis will be conducted to characterize functional domains in the protein. Proteins that interact with DotA will be identified using molecular and genetic assays. The in vivo role of dotA will be determined by comparing the molecular biogenesis of L. pneumophila phagosomes that are formed by both wild type and dotA mutant bacteria. Studying the structure and function of the DotA protein will provide a foundation for our understanding of how intracellular bacterial pathogens that grow within the phagolysosome are able to exploit host cellular processes to establish infection.